Title: Development and Validation of Therapy for GM1 Gangliosidosis

PROJECT SUMMARY
GM1 gangliosidosis is lysosomal storage disease in which a key hydrolase enzyme, known as beta-
galactosidase is missing in the lysosome resulting in the toxic accumulation of complex sugars called
gangliosides, in particular GM1 and GA1 principally in the central nervous system. There is currently no cure or
effective treatment available. A primary approach for treating related types of disorders involves replacement of
the missing enzyme by injection into the circulation. Although intravenous enzyme replacement therapy (ERT)
resolves many aspects of the disease, unfortunately it does not resolve complications of the disease in the
CNS. Although, ERT is not a cure for this disease it can have a marked effect on the patient’s development
and thus quality of life. Intravenous ERT has been successfully commercialized for lysosomal
mucopolysaccharidoses (MPS) disorders with approved drugs on the market, including (i) Laronidase for MPS
I (Aldurazyme®, alpha-iduronidase, Hurler Syndrome), (ii) Idursulfatase for MPS II (Elaprase®, iduronate-2-
sulfatase, Hunter Syndrome) and (iii) Vestronidase alfa for MPS VII (Mepsevii™, beta-glucuronidase, Sly
Syndrome). Intracerebroventricular (ICV) ERT has also been successfully commercialized for a progressive
neurodegenerative lysosomal disease called Batten disease. Cerliponase Alfa (Brineura®, tripeptidyl
peptidase-1) is a lysosomal enzyme delivered via ICV infusion directly to the brain to replace the deficient
enzyme. This therapy is the first safe and effective ICV ERT approved for direct delivery to the brain. A Phase
II clinical trial is also underway using a modified lysosomal enzyme ICV-delivered directly to the brain.
Together, the FDA and investors are familiar with ERT and its commercialization path forward, both of which
are essential in reaching a clinical trial. This proposal focuses on the development of the ICV route of
administration to perform ERT directly to the central nervous system and its application to treating GM1
gangliosidosis. GM1 gangliosidosis has severe neurodegenerative symptoms with no current therapies
available due to poor transport across the blood-brain barrier. In our studies, we will engineer cells to produce
sufficient quantities of recombinant human beta-galactosidase enzyme for testing in GM1 gangliosidosis
knockout mice. These mice will be ICV-administered enzyme and analyzed for dose-dependent biodistribution
of the enzyme and effects on biochemical and histological pathology will be evaluated. Efficacy and safety will
be assessed in single intermittent dose; once a week for 8 weeks dosing study. The results will provide the
preclinical information needed to proceed towards a novel treatment of the disease in humans.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to develop a novel method of enzyme delivery to the brain. Intravenous enzyme replacement therapy has proven successful for treating the somatic symptoms of lysosomal storage disorders, but delivery to the central nervous system is problematic because intravenously injected enzymes do not penetrate the blood brain barrier. In this proposal, we test an intrathecal delivery; known as intracerebroventricular, which provides direct injection to the brain and therefore bypasses the blood brain barrier, as a therapy for treating patients with GM1 gangliosidosis. GM1 gangliosidosis is a lethal childhood disease that is currently without any treatments. Previous clinical trials as well as ongoing clinical trials with lysosomal enzymes as drugs for treating other lysosomal diseases suggest that an intracerebroventricular delivery approach has a very high probability of success.